Tau biomarkers in late-onset psychosis

ABSTRACT/PROJECT SUMMARY
Psychotic symptoms that occur in advanced age in the absence of an acute medical condition or prominent
mood symptoms can represent the late appearance of primary psychotic disorders such as schizophrenia or
delusional disorder or can presage the appearance of a neurodegenerative condition such as Alzheimer’s
disease (AD). An episode of non-affective psychosis late in life more than doubles the risk of subsequent
neurodegenerative disease, with an average time from psychosis to AD diagnosis of 18 months. The biologic
mechanisms responsible for the increased risk of dementia in those who experience psychosis are unclear.
One hypothesis is reverse causality, in which inchoate neurodegeneration is responsible for psychotic
symptoms that emerge in the absence of traditional cognitive hallmarks of dementia. The psychosis then
heralds the inception of illness that will eventuate in cognitive decline. An increased burden of tau pathology
has been associated with psychosis in AD. In the current pilot study will utilize PI-2620, a novel tau positron
emission tomography (PET) ligand, together with single molecule array (SiMOA) peripheral fluid
immunoassays to investigate whether there is evidence of elevations in tau biomarkers in a cohort of late-onset
psychosis subjects without cognitive impairment. At the completion of this exploratory study, we will know
whether there is evidence of tau pathology from high-sensitivity biomarkers in late-onset psychosis that would
warrant a larger R01 study that would be focused on longitudinal outcomes assessing the influence of tau
biomarker positivity on the risk of conversion to dementia over time.

Public health relevance
PROJECT NARRATIVE In elderly people, an episode of psychosis characterized by the development of delusions or hallucinations increases the risk of subsequently developing dementia; the biologic mechanism(s) responsible for this increased risk are poorly understood. Tau proteins in the brain, known to increase the risk of Alzheimer’s disease psychosis, may be responsible for the increased risk of dementia in people who become psychotic. The current application will use novel brain imaging and peripheral blood tests to measure tau proteins in elderly people who have become psychotic to determine whether tau may be a risk factor.